Task A27: Immunogenicity Study of a Live Attenuated Vibrio Cholerae Vaccine in Mice

This contract provides for the development and standardization of small animal models of infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.